Western Neurotrauma Symposium

PROJECT SUMMARY/ABSTRACT
Traumatic brain injury (TBI) is one of the top causes of death and disability worldwide. However, due to its
complexity, it remains one of the most challenging neurological conditions to treat. Advances in our
understanding of TBI pathobiology and improvements in clinical care for TBI require multidisciplinary exchange
of scientific ideas and encouragement of promising young investigators in the field. Our first Western
Neurotrauma Symposium (WNTS) was well received and especially noted for the attention given to the trainees
and early investigators. The WNTS will continue to be a unique regional conference providing an annual venue
for a broad range of neurotraumatology research, with a focus on trainees and early career investigators,
presentation of cutting-edge data in a safe environment, multidisciplinary collaborative ideas and a more intimate
setting to allow direct interactions between attendees. This meeting will be instrumental in developing the next
generation of investigators and ideas, without duplicating or replacing opportunities provided at existing National
and International Neurotrauma Symposia. While the focus of continued WNTS funding would be development
of regional young investigators and collaborators, attendance at the meeting would be open. The first WNTS
showed participation of a more diverse population from centers throughout the Western U.S. with specific
outreach and travel awards to encourage active participation of underrepresented groups in
neuroscience/neurotrauma research. In 2022, this R13 supported 6 WNTS Young Investigators, 9 WNTS Travel
Awardees and 2 WNTS Faculty, enhancing diversity at all levels. The additional support provided by renewing
this grant for 2023 would specifically enable expanded inclusion of investigators from outside of the UC, bringing
in research and clinical trainees and faculty from across the western states, for whom travel, expense and time
constraints may limit opportunities for young persons to attend national or international conferences.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury (TBI) is one of the top causes of death and disability worldwide, and one of the most challenging neurological conditions to treat due to its complexity. A multidisciplinary exchange of scientific ideas between trainees and investigators at all levels is therefore necessary to continue advancing our understanding of TBI, and to improve clinical care and public health outcomes. Our first Western Neurotrauma Symposium (WNTS) provided a forum for scientists and clinicians from across the western United States to spotlight our trainees and early investigators and has already initiated collaborations sharing data; in 2023 we will continue WNTS to expand diversity and inclusivity in our field, generate new ideas and develop future research grant opportunities.